Biomechanics and Hemodynamics of Human Aorta with Remodeling after Endovascular Repair

PROJECT SUMMARY
Type-B aortic dissection is a disease with a tear of the intimal layers of the aorta distal to the aortic arch and
separation of the wall layers in the thoracic aorta, which may extend further. It is rare but life-threatening when
left untreated since the weakened aortic wall could rupture resulting in internal bleeding, and the false lumen
may disrupt the normal blood supply to the kidneys, intestines, and spinal cords. As a less-invasive surgical
treatment, thoracic endovascular aortic repair (TEVAR) covers the dissected aorta with an endograft by
inserting it through a distal vessel and deploying at the dissected region to seal the tear. Major concerns
persist with the long-term TEVAR outcomes when multiple endografts and stents are implanted to treat
extensive dissection. Two or more endografts are needed to cover extensive dissection since there is no
standalone endograft which can cover the entire region. Extensive use of endografts can impact the
biomechanics and hemodynamics of the aorta which requires careful pre- and post-TEVAR planning. After
TEVAR, the aorta undergoes remodeling over time. Regular monitoring with computed tomography (CT) is
necessary to keep track of aortic remodeling. The common radiographic features including aortic diameter and
luminal volume are insufficient to predict long-term aortic remodeling. This investigation addresses the unmet
need to assess the long-term impact of multiple endografts on the aorta. To this end, we will identify the key
features to quantify aortic remodeling during the 1-year follow-up period. This investigation aims to
characterize the long-term impact of extensive TEVAR on the aorta by identifying underlying biomechanical
and hemodynamic features due to this condition. This will be achieved by identifying biomechanical features to
characterize aortic remodeling triggered by extensive TEVAR (Specific Aim 1) and evaluating the impact of
blood flow on aortic remodeling during the long-term follow-up (Specific Aim 2). To achieve these aims, we will
utilize patient-specific CT at pre-, post-TEVAR, and 1-year follow-up, computational modeling, computational
fluid dynamics, and feature correlation. Outcomes of this investigation will provide powerful features
representing the adaptation of the aorta to extensive TEVAR and help guide optimal surgery to promote
favorable aortic remodeling. Our techniques of feature identification using patient-specific CTs and
computational analysis will be valuable in refining patient selection criteria for extensive TEVAR, helping
strategic decisions for surgery, and planning for post-surgical surveillance.

Public health relevance
PROJECT NARRATIVE This investigation addresses the clinical need to assess the long-term impact of thoracic endovascular aortic repair using multiple endografts for the dissected aorta, by identifying the key biomechanical and hemodynamic features to characterize aortic remodeling. The proposed technology will provide essential data to select the patients who can expect a favorable outcome, help find the optimal composition of devices to treat the patient, provide a reliable guideline for CT-based feature extraction to track the long-term aortic remodeling during the follow-up period and determine the optimal interval to acquire the follow-up CTs. The results data will be applicable to improve the current endograft design to the next level to treat extensively dissected aorta.